Training in Biomedical Informatics at Columbia University

PROJECT SUMMARY
Columbia University's biomedical informatics training program seeks to advance the discipline of biomedical
informatics by providing a broad and rigorous formal course exposure paired with intense research training in
a strong health-focused environment. Our program is run by Columbia's Department of Biomedical
Informatics, and it offers an exceptionally rich environment as it is closely tied to NewYork-Presbyterian
Hospital, the Columbia Data Science Institute, and departments and schools throughout the university. We
have a large, internationally recognized faculty with consistent involvement in national biomedical informatics
projects. In addition, our clinical information systems service responsibilities offer trainees opportunities to get
first-hand exposure to, and training on, state-of-the-art clinical and research information systems. Funded by
NLM since 1992, our program has produced many informatics leaders, including chairs, directors, senior
research faculty, and ACMI fellows, and it has graduated 91 pre-doctoral PhD students (49 NLM trainees) and
75 NLM postdocs. Our graduate programs received over 100 applications this year.
Our curriculum includes a biomedical informatics core, additional courses in data science, artificial
intelligence, and machine learning, qualitative methods, information technology methodology, courses in the
application domains, extensive research experience throughout the training period, teaching experience, and
dedicated instruction on ethics. We cover five application areas— health care/clinical informatics, translational
bioinformatics, clinical research informatics, public health informatics, consumer health informatics— and
propose a new specialization dedicated to informatics and data science for HIV research. We cover three
educational end-points— pre-doctoral PhD (generally for 3-5 years), post-doctoral MA and PhD (generally for
2-3 years), and post-doctoral non-degree for those trainees with previous informatics doctoral training
(generally for 2-3 years)— as well as short-term positions. We request 12 pre-doctoral slots (including 2 for the
new Informatics and Data Science for HIV specialization), 5 post-doctoral slots, and 4 short-term trainee
positions (2 pre-doctoral and 2 post-doctoral).

Public health relevance
PROJECT NARRATIVE The goal of Columbia University's training program is to advance health care and medicine through the advancement of the discipline of biomedical informatics. Our training program provides a research-oriented curriculum with rigorous formal training in informatics and data science integrated with exposure to real- world systems in clinical and research settings at our university, in our community, and around the world. Most of our graduates continue to advance the field through research as faculty members in academic institutions or in industry-based research facilities.